Diversity supplement for R01DE029479-01A1 to support Dr. Jeremy Elias

Abstract: In today's microbiome era, it is well-recognized that dental caries, one of the most prevalent and costly
chronic infectious diseases world-wide, results from dysbiosis of the oral microbiota and the oral environmental
changes that cause tooth damage. Specifically, frequent intake of fermentable carbohydrates promotes a
progressive shift in microbial composition toward acidogenic and acid-tolerant species. The continual acid-
induced demineralization eventually overcomes the buffering capacity and anti-microbial properties of saliva,
leading to irreversible tooth destruction. The goal of this proposed research is to prevent dental caries through
targeted treatment of acid-producing bacteria (t-TAB). t-TAB will facilitate a healthy microbial community that
are vital in modulating pH and preventing acid-induced teeth damage. The t-TAB will be achieved by selectively
inhibiting the growth of cariogenic bacteria through enhanced antimicrobial (AM) efficacy in response to the
accelerated/aggravated caries-causing acid production in comparison to commensal species. We propose four
specific aims to develop, identify and assess the effective t-TAB candidates. In Specific Aim 1, we will synthesize
and characterize six new pH-sensitive quaternary pyridinium salts (pH-QPSs). We expect to identify compounds
or combinations of compounds that provide t-TAB in aqueous mixtures. We will enhance our understanding of
the chemical structure/AM efficacy relationship and optimize the AM efficacy and solubility of pH-QPS(s) to
obtain safe and effective t-TAB treatment. In Specific Aim 2, we will empower a clinically tested AM agent,
chlorhexidine (CHX), with pH-sensitive AM efficacy (pH-AM-E) and transform it into a t-TAB agent. We will
achieve acid enhanced CHX release through encapsulated CHX in QPS-functionalized mesoporous silica
nanoparticles. We will also identify the synergistic pH-AM-E induced by interactions of CHX and pH-QPSs. In
Specific Aim 3, we will assess and compare the t-TAB efficacy of lead candidates from Aim 1 and Aim 2 by
employing a multispecies biofilm model that simulates human oral microbial community (named O-mix). The t-
TAB efficacy will be assessed in the presence and absence of sucrose—the cariogenic dietary carbohydrate.
Strategy will entail evaluating biomass, analyzing microbial profiles and determining environmental pH. Finally,
the most effective t-TAB candidates that successfully inhibit the growth of cariogenic acid-producing bacteria
while keeping the commensal species in working conditions, e.g., maintaining pH above 5.5, will be further
assessed in Specific Aim 4 in vitro using an in vitro microbial-caries model on human enamel and in vivo
employing a well-developed mouse caries model. Successful completion of the proposed aims will provide new
materials for oral rinse in dental clinics to prevent/treat dental caries. Knowledge gained from this study will also
advance material development to prevent infection and erosion.

Public health relevance
Narrative: The proposed research focuses on prevention of dental caries through targeted treatment of acid- producing bacteria (t-TAB). Its goal will be achieved by formulating and developing a series of pH-sensitive quaternary pyridinium salts and empowering the traditional, non-pH-sensitive chlorhexidine with t-TAB capability. The successful candidates capable of preventing acid-induced tooth damage through achieving a healthy microbial community and maintaining environmental pH above 5.5 will be identified using a multispecies biofilm model that simulates human oral microbial community and further assessed for caries prevention in vitro using a microbial-caries model on human enamel and in vivo through a well-developed mouse caries model .